Laminin control of synaptic function and dendritic stability

DESCRIPTION (provided by applicant): During development, dendrites and dendritic spines form and turn over dynamically. In adult brains, however, most dendrite branches and many dendritic spines are stable. Defects in dendrite arbor and dendritic spine stability underlie numerous psychiatric and neurological diseases, including late-onset disorders such as schizophrenia, Major Depressive Disorder, and Alzheimer's disease. I provide evidence in this proposal that loss of the extracellular matrix protein laminin α5 specifically from excitatory neurons disrupts spine stability, causes dendrite regression during adolescence, and compromises normal synaptic transmission and animal behavior. In my research plan, I propose to identify which synaptic partner produces the necessary laminin α5, determine when it functions to stabilize dendritic structure and synaptic transmission, and test whether activity changes cause spine stability disruption found in laminin α5 knockout neurons. Aim 1. To elucidate where the α5-containing laminin is produced and when it is necessary. My preliminary data show that loss of laminin α5 specifically from excitatory forebrain neurons causes dendrite loss and synaptic dysfunction in CA1 neurons starting after P21. I also show that adult excitatory neuron- specific laminin α5 KO mice lack laminin α5 protein specifically near synapses. Which synaptic partner provides this laminin is a fundamental and unresolved question. Knowledge of its source is critical to understanding how its expression, processing, and secretion are controlled, and ultimately what factors govern dendritic stability. To address this, I will selectively inactivate the lama5 gene in presynaptic (CA3) or postsynaptic (CA1) cells and then measure dendritic arbors, dendritic spine density, and synaptic currents in the postsynaptic neuron. Another critical question is when laminin α5 functions to control these phenotypes. To determine this, I will use inducible genetic inactivation of laminin α5 at time points before, during, and after adolescence and then measure dendrite arbors, dendritic spines, and synaptic currents. Aim 2: To determine whether synaptic transmission defects drive dendritic spine destabilization in laminin α5 knockout neurons. My preliminary studies indicate that acute hippocampal slices from excitatory- specific laminin α5 knockout mice exhibit increased currents at CA3:CA1 synapses beginning after P21. I also find cultured laminin α5 KO neurons exhibit decreased spine density, increased spine head width, and increased spine size fluctuations relative to WT neurons. These phenotypes can all be rescued with application of exogenous α5-containing laminin. A fundamental question that arises from these studies is whether the increased currents at laminin α5 KO synapses drive the loss of dendritic spine stability. To test this possibility, I will use calcium imaging to test whether rescue with exogenous α5-containing laminin attenuates calcium transients before rescuing spine fluctuation and also whether restoring WT activity levels restores normal spine fluctuation, density, and morphology in laminin α5 KO neurons.

Public health relevance
PUBLIC HEALTH RELEVANCE: Neurons have exceptionally detailed shapes that enable precise connections to other neurons and thereby proper brain function. My proposed studies will uncover where, when, and how a certain laminin molecule acts to maintain the shape and connections of neurons in the brain, properties that are disrupted in psychiatric and neurodegenerative diseases. This work could lead to new therapeutic strategies to combat and repair structural abnormalities in neurons.